Impact of Positive Airway Pressure Therapy on Clinical Outcomes in Older Veterans with Chronic Obstructive Pulmonary Disease and Comorbid Obstructive Sleep Apnea (Overlap Syndrome)

Cognitive dysfunction in the aging and elderly Veteran population confers a risk for increased mortality.
Cognitive deficits are prevalent in neurodegenerative disorders, like Alzheimer’s disease, stroke, and
depression. More recently, obstructive sleep apnea (OSA) has been recognized as a factor contributing to
cognitive deficits via intermittent hypoxia and sleep fragmentation. Moreover, chronic lung disease, particularly
COPD, is also thought to be related to cognitive decline, possibly through sleep fragmentation and hypoxic
injury to the brain. Our pilot project data on the impact of OSA-COPD Overlap Syndrome in older Veterans
provides evidence that the presence of comorbid OSA and COPD does contribute to sleep disturbances,
impairment in certain domains of cognitive function and an overall reduced quality of life (QoL). Given that PAP
therapy has been shown to improve neurocognitive function and sleepiness in moderate to severe OSA,
probably by reducing arousals and hypoxia, as well by improving sustained hypoxia due to COPD, it will likely
also have a positive impact on sleep and cognitive impairment in patients with moderate to severe degree of
Overlap Syndrome. The results from the pilot project speak to the feasibility of conducting a future longer study
of the impact of treatment with positive airway pressure therapy (PAP) vs. conservative care in older Veterans
with Overlap Syndrome. Our future project builds on the pilot data to study the following aims:
Aim1 will investigate the effect of PAP therapy vs. conservative care for 6 months on daytime sleepiness and
sleep quality in older Veterans with OVS. Aim 2 will study the effect of PAP vs. conservative care for 6 months
on neurocognitive function older Veterans with OVS. Aim 3 will determine the effect of PAP vs. conservative
care for 6 months on QoL in older Veterans with OVS. The approach will be a prospective parallel group
randomized controlled study, wherein we will administer sleep and QoL questionnaires, and a battery of
cognitive tests, before and after 6 mo of PAP therapy or conservative management to evaluate the above
outcomes. Our goal is to enhance rehabilitation from comorbid chronic conditions that frequently impact sleep
and cognitive function, with the ultimate objective of improving the overall health and quality of life of elderly
Veterans suffering from these disorders.

Public health relevance
It has increasingly become evident that obstructive sleep apnea (OSA) is negatively associated with adverse neurocognitive consequences. The negative neurocognitive consequences of OSA in the elderly may be compounded by the co-existence of another disorder, chronic obstructive lung disease (COPD). The combined effect of these two highly prevalent diseases, OSA and COPD, also known as Overlap Syndrome, may put the elderly Veteran at increased risk for developing early dementia, poor functional health and poor quality of life. Our goal is to advance the rehabilitative health care of elderly Veterans at increased risk for cognitive impairment and sleep disturbances by evaluating effective treatment pathways, with the aim of improving overall health and quality of life.